Anakinra Dosing in Children with Sepsis Induced MODS: A Physiologically Based Pharmacokinetic-Pharmacodynamic Approach

PROJECT ABSTRACT
Treatment of children with sepsis-induced multiple organ dysfunction syndrome (MODS) requires
optimal dosing of drugs. Drug dosing may need to be adjusted in these children because of altered drug
pharmacokinetics (PK) and pharmacodynamics (PD), resulting from: 1) inflammation and capillary leak leading
to increased volume of distribution; and 2) organ dysfunction causing decreased drug clearance. The impact of
these alterations can be quantified using physiologically based pharmacokinetic-pharmacodynamic (PBPK-PD)
modeling.
Anakinra is an interleukin-1 receptor antagonist (IL-1Ra) that is FDA approved to treat
hyperinflammatory syndromes in children. The use of anakinra in children with sepsis-induced MODS is
currently being evaluated in the Personalized Immunomodulation in Pediatric Sepsis-Induced MODS
(PRECISE) trial, a multi-center randomized control trial wherein children are randomized to receive anakinra or
placebo if they have sepsis-induced MODS with hyperinflammation. In this population, optimal dosing of
anakinra is unknown. In addition, the role and kinetics of endogenous IL-1Ra is unknown. These gaps in the
understanding of anakinra PK and PD place these children at risk for treatment failure and toxicity.
The objective of this proposal is to leverage the PRECISE trial to evaluate the impact of sepsis-induced
MODS on the kinetics of endogenous IL-1Ra and anakinra. Based on these results, we will use a PBPK-PD
modeling approach to determine a safe and efficacious anakinra dosing regimen. Specifically, the proposed
work will 1) characterize the kinetics of endogenous IL-1Ra in children with sepsis-induced MODS who receive
placebo in the PRECISE trial; 2) incorporate relevant drug and population specific factors into a PBPK-PD
model to predict anakinra disposition and efficacy; 3) validate the model using prospective data obtained from
children receiving anakinra in the PRECISE trial and establish a model- and biomarker-informed anakinra
dosing regimen. Training will take place at the University of Utah under the mentorship of a pediatric trialist and
leading expert in PBPK modeling. Through my training plan, I will develop the necessary skills for a career as
an independent physician scientist including training in advanced pharmacology, clinical trial design, scientific
communication, and sophisticated modeling and simulation techniques.

Public health relevance
PROJECT NARRATIVE This study will enhance public health by characterizing the pharmacokinetics and pharmacodynamics of anakinra in children with sepsis-induced multiple organ dysfunction syndrome. Specifically, the work outlined in this proposal will result in model- and biomarker-informed anakinra dosing recommendations in this high-risk, vulnerable population. This research will provide a dosing platform that will advance pediatric drug development and enable optimal, patient-specific pharmacotherapy in critically ill children.